SCREENING NEWBORNS FOR SEPSIS USING A DNA PROBE

The primary aim of this project is to ascertain the sensitivity and specificity of generic DNA probes on infant blood culture samples in the detection of bacterial infection following 8 to 14 hours of routine incubation. Specifically blood samples will be taken from incubating blood cultures orginating from the newborn intensive care nurseries. The samples will be obtained, processed and mailed to a central laboratory by UNMH microbiology laboratory personnel.